Dystonia Coalition- Career Development

PROJECT SUMMARY
The overall goal of the Dystonia Coalition Career Enhancement Program is to promote career development for
investigators interested in research in dystonia and related rare disorders. The program has two objectives. Aim
1, the main objective, is to provide a Career Enhancement award to encourage investigators to pursue research
projects relevant to dystonia. The anticipated candidates for this Award will be advanced post-doctoral clinical
research fellows, senior clinical fellows, or early-stage junior faculty members aiming to become independent
investigators. Candidates may also be more senior non-dystonia investigators interested in getting involved in
dystonia research. Aim 2 is to provide a Travel Stipend for interested participants to attend meetings such as
the annual Dystonia Coalition meeting to learn more about rare diseases research. The anticipated candidates
for this stipend include interested participants at all levels, including junior clinical or research fellows, clinical
residents, graduate students, and medical students.

Public health relevance
NARRATIVE According to RFA-18-020, the narrative is not to be completed for the Career Enhancement Program Section.